Establishing IFPTI as the Integrated Food Safety System (IFSS) Regulatory and Laboratory Training System (RLTS) National Coordination Center (NCC) and Learning Management System (LMS)

RFA-FD-25-005 – Project Summary/Abstract
The International Food Protection Training Institute (IFPTI) proposes to be established as
the Integrated Food Safety System (IFSS) Regulatory and Laboratory Training System
(RLTS) National Coordination Center (NCC) and Learning Management System (LMS).
Given its longstanding history of collaboration with FDA (through three consecutive
Cooperative Agreements) and its leadership role in designing and developing the Human
and Animal Food NCS and Laboratory NCS, IFPTI is uniquely positioned to assume the
role of the NCC to continue the implementation of the RLTS across the IFSS.
The proposal comprises three primary Aims, all of which comprise a series of sub-aims
outlined in the Research Strategy.
Aim #1 focuses on Training Content, Design, and Delivery, and will primarily involve
reviewing and standardizing mapping processes and procedures to the NCS.
Accomplishing Aim #1 will require collaborating with IFSS partners and stakeholders on
training content development; maintaining the NCS; creating competency profiles and
learning pathways; researching alternative ways of demonstrating competency; and
addressing learner needs and accessibility.
Aim #2 focuses on Management and Maintenance, and will primarily involve managing
and maintaining the IFSS RLTS and LMS. Accomplishing Aim #2 will require standing up
and managing the NCC; employing fee structures for sustainability; facilitating
collaboration through supporting the RLTS Steering Committee; outreach and
communication activities; training provider recruitment; and supporting the operation of
the National LMS.
Aim #3 focuses on Collaboration and Consistency, and will primarily involve collaborating
with IFSS stakeholders to ensure the effectiveness, consistency, and quality of training.
Accomplishing Aim #3 will require assuring the quality of learning resources;
implementing the RLTS quality assurance system (SCORE Process); instructor
management activities; data collection activities to allow for continuous improvement; and
a wide range of evaluation activities.

Public health relevance
RFA-FD-25-005 – Project Narrative The International Food Protection Training Institute (IFPTI) is submitting this proposal to be established as the Integrated Food Safety System (IFSS) Regulatory and Laboratory Training System (RLTS) National Coordination Center (NCC) and Learning Management System (LMS). The proposal comprises three primary Aims: 1) Training Content, Design, and Delivery, which will focus on reviewing and standardizing mapping to the National Curriculum Standard (NCS); 2) Management and Maintenance, which will focus on managing and maintaining the IFSS RLTS and LMS; and 3) Collaboration and Consistency, which will focus on collaboration with stakeholders to ensure the effectiveness, consistency, and quality of training. Given its longstanding history of collaboration with FDA and its leadership role in designing and developing the Human and Animal Food NCS and Laboratory NCS, IFPTI is uniquely positioned to assume the role of the NCC to continue the implementation of the RLTS across the IFSS.